Comparing a Novel Telehealth-enabled Hybrid Cardiac Rehabilitation Program to Clinic-based Cardiac Rehabilitation for Improving Patient Engagement, Functional Outcomes, and Health Equity after ACS

PROJECT ABSTRACT
Cardiac rehabilitation (CR)—which involves exercise training, patient education, and health behavior
modification—is a comprehensive intervention traditionally delivered in clinic-based settings, with the highest
recommendation and level of evidence classification (i.e., Class I, Level A) for secondary prevention. Traditional
CR significantly reduces rates of reinfarction (by 47%) and both cardiac (36%) and all-cause mortality (26%) in
acute coronary syndrome (ACS) survivors, an extremely sedentary population whose functional status and
health-related quality of life (HRQOL) improve after CR participation. Despite the well-established effectiveness
of traditional CR—benefits achieved through continued program participation (i.e., adherence), fewer than 10%
of eligible ACS patients in the US who initiate CR (<30%) attend all prescribed CR sessions, with even lower
rates among racial and ethnic minoritized groups. Dismal participation in traditional CR programs and stark
utilization disparities that have endured for decades highlight the need to design nontraditional CR models (e.g.,
virtual, hybrid) and rigorously test whether such models can deliver the same quality of traditional CR while
equitably improving patient participation among diverse groups of cardiac patients. To address this need, our
group combined user-centered design (UCD) and implementation science (ImS) principles and methods to
design and test the feasibility of a telehealth-enhanced hybrid CR program (TeleheartCR; mixture of in-person,
clinic and virtual, home sessions with a telehealth platform that supports real-time monitoring and electronic
health record [EHR] data integration). This program targets patient-, provider-, and system-level barriers in a
large hospital setting that serves diverse patients. Now, we propose to conduct a single-site, single-blind, two-
arm, parallel group, randomized controlled trial to determine the degree to which TeleheartCR equitably improves
CR participation and clinical outcomes relative to traditional CR among ACS patients. We hypothesize that
participants allocated to TeleheartCR will demonstrate greater program adherence (% of CR sessions
completed) and non-inferior functional capacity (pre-to-post program change in six-minute walk test [6MWT]
distance) vs participants allocated to traditional CR. Both CR programs include 24 CR sessions over 3 months.
Program attendance, and a 6MWT at baseline and program completion, will be collected and extracted from the
EHR. Self-reported program acceptability, appropriateness, and HRQOL will be secondary outcomes. We will
also explore the comparative costs and cost-effectiveness (TeleheartCR vs. traditional CR), as well as whether
racially, ethnically, and socioeconomically minoritized groups particularly benefit. Findings will inform the design
and implementation of innovative hybrid delivery models to achieve equitable utilization of established
interventions in hospital settings that serve diverse patients. More broadly, if our hypotheses are supported, this
study will illustrate the power of UCD and ImS to deploy technology in the service of closing evidence-to-practice
gaps and reducing disparities in healthcare access and persistence.

Public health relevance
PROJECT NARRATIVE Cardiac rehabilitation (CR) is an effective evidence-based intervention that improves event-free survival in cardiac patients through continued program participation, but fewer than 10% of all eligible patients who receive CR (<30%) in the United States attend all prescribed CR sessions, with even lower rates observed among racial and ethnic minoritized groups. A hybrid CR intervention that combines optimal features of telehealth, home-, and clinic-based CR (i.e., TeleheartCR) could increase CR participation by addressing structural barriers to access, while retaining the functional capacity benefits for which CR is known. The goal of this proposal is to conduct a randomized controlled trial comparing TeleheartCR with traditional clinic-based CR in a diverse group of cardiac patients to test differences in (1) program adherence (% of total sessions completed), and (2) pre-to-post program change in functional capacity.